Pelvic Floor Disorders Network Data Coordinating Center Administrative Supplement: ODSS CDE Funding

Project Summary/Abstract
Since its establishment in 2001, the Eunice Kennedy Shriver National Institute of Child Health
and Human Development (NICHD) has been instrumental in supporting the collection, analysis,
and dissemination of data from pelvic floor disorder studies through the Pelvic Floor Disorders
Network (PFDN). Over the years, the PFDN has systematically vetted and reused standard data
collection instruments specific to pelvic floor disorder studies research, laying the groundwork
for the development of common data elements (CDEs). This project will create standardized
CDEs for the pelvic floor disorders research community to enhance data consistency and
comparability across studies.

Public health relevance
Project Narrative The PFDN was established in 2001 to improve the care of women with PFDs by conducting well- designed multicenter studies to inform diagnosis, prevention, and treatment. A qualified, experienced DCC is critical in helping the PFDN optimize research productivity through effective study design, implementation, data collection, quality assurance, monitoring, and statistical analysis. RTI will continue to provide multidisciplinary expertise to support high impact collaborative clinical research studies and provide communications and logistical support to optimize the efficiency and productivity of the Network.